"A PHASE I STUDY INVESTIGATING THE SAFETY & EFFICACY OF DANVATIRSEN AS MONOTHERAPY FOLLOWED BY COMBINATION WITH VENETOCLAX IN PATIENTS WITH RELAPSED/REFRACTORY MDS & AML."

Project Summary/Abstract
Myeloid malignancies such as myelodysplastic syndrome (MDS) & acute myeloid leukemia
(AML) emerge and are propagated through expansion of disease-initiating aberrant
hematopoietic stem cells. Although newer approved therapies have improved outcomes in these
diseases, relapse continues to be the most common cause of death in aggressive myeloid
malignancies (MDS & AML) with a dismal prognosis of 4-10 months in R/R HR-MDS and R/R
AML. Disease-initiating leukemic stem cells are a source of disease relapse and need to be
targeted for potentially curative therapeutic strategies. Signal transducer and activator of
transcription 3 (STAT3) belongs to the STAT family of transcription factors that are
inappropriately activated in several malignancies. Our preliminary data indicate that STAT3 is
demethylated and overexpressed in MDS/AML stem cells and was associated with an adverse
prognosis in a large cohort of patients (Shastri et al, JCI 2018) . We have also demonstrated
that STAT3 controls several important leukemic drivers such as the antiapoptotic protein
myeloid leukemia cell differentiation 1 (MCL1). MCL1 overexpression is an important mediator
of resistance to BCL2 inhibition (venetoclax) in R/R AML/MDS. Danvatirsen (AZD9150) is a
selective antisense inhibitor of STAT3 that can target malignant stem cells while sparing healthy
control hematopoietic stem and progenitor cells (HSPC), thus identifying it as a potential
therapeutic strategy in MDS/AML (Shastri et al, JCI 2018).
Through the means of this grant proposal we will study the safety, efficacy & target-selectivity of
danvatirsen as monotherapy & in combination with Ven in a phase I clinical trial for patients with
R/R high-risk MDS & R/R AML. We also aim to evaluate biomarkers of STAT3 inhibition as well
as downstream MCL1 inhibition in parallel with the ongoing clinical trial.
Through Aim. 1 we will determine the safety, efficacy & on-target effect of the STAT3
inhibitor danvatirsen as an antileukemic stem cell therapy in an early-phase clinical trial
in R/R high-risk MDS and AML. We will employ a phase I dose escalation protocol that
includes 2 sub-studies to evaluate the safety profile and determine the maximum tolerated dose
(MTD) of : a) danvatirsen as monotherapy, b) combination of danvatirsen and venetoclax once
safety of danvatirsen monotherapy is established. The primary objective of the study is to
establish the safety, the maximum tolerated dose (MTD) & recommended phase 2 dose (RP2D)
of danvatirsen monotherapy followed by combination with venetoclax for the treatment of R/R
Int/high/very-high-risk IPSS-R MDS or R/R AML. The secondary objective of the study is to
determine the duration of response (DOR), event-free survival (EFS), overall survival (OS), 30-
and 60-day all cause mortality, minimal residual disease clearance in responders (based on
multiparametric flow-cytometry, number bridged to stem cell transplantation).
For Aim 2. of the study, we will determine biomarkers of response as well as evaluate on-
target efficacy against leukemic stem cells in correlative studies. Our exploratory objectives
are to identify pretherapy and on-therapy clinical, mutational and stem cell correlates of response
to STAT3 inhibition as well as understand the STAT3-associated gene expression changes in
aberrant MDS/AML LSC’s. To this end, we will isolate stem and progenitor cells from patients
prior to treatment and at pre-specified time points on therapy to assess the uptake and molecular
effects of danvatirsen including on STAT3 expression/phosphorylation in aberrant MDS/AML
LSCs. We have obtained an IND for the proposed trial from the FDA as well as a letter of support
for provision of danvatirsen from Flamingo therapeutics for the entire duration of the clinical trial.

Public health relevance
Project Narrative Aggressive myeloid malignancies such as high-risk myelodysplastic syndromes (MDS) and acute myeloid leukemia (AML) are difficult to treat and frequently not cured by conventional chemotherapy. Relapsed/refractory (R/R) MDS/AML have a very poor prognosis. Through the means of this proposal, we will conduct an early phase clinical trial of a novel antisense STAT3 inhibitor in patients with R/R MDS/AML and also investigate ways to overcome therapy resistance in MDS/AML.